NADPH-oxidase 2 inhibitors for cardiovascular indications

The goal of this project is to identify small molecule inhibitors of NOX2 activity as a strategy for counteracting atherosclerosis.

During this period, the research team screened tens of thousands of small molecules for inhibitors of NOX2 activity. Hits were cherrypicked and validated for activity, and a set of biochemical assays and cell culture models will the further utilized to remove compounds that possess non-specific or undesirable activities. Compounds with promising activity profiles will be considered for advancement to medicinal chemistry for structure activity-guided optimization, and for further investigation in advanced models. Synthesized analogs are currently being characterized, and focused medicinal chemistry efforts remain ongoing.